Molecular targeting the translational control axis in Wnt/beta-catenin signaling pathway

Gene expression is regulated mainly at both transcriptional and translational levels.
Compared with transcriptional regulation, translational control is under-studied and the roles of
eukaryotic initiation factors (eIFs) in regulating gene expression, in signal transduction, and in
regulating cell growth have not been appreciated to the level of their importance. The prevailing
theory of translational control in gene expression is that the expression level of eIFs directly
relates to the rate of translation initiation and level of protein synthesis. According to this theory,
the increased expression of eIFs such as eIF4E, a putative subunit of eIF4F complex, would
increase translation initiation rate and protein synthesis. However, we recently found that over-
expression of eIF3a, a putative subunit of eIF3 complex, inhibited synthesis of tumor suppressor
proteins and caused malignant transformation of intestinal epithelial cells. We also found that
eIF3a expression was up-regulated in colon cancers and adenoma polyps possibly due to APC
mutation and activation of β-catenin signaling. We hypothesize that eIF3a may serve as a
turning point in the canonical Wnt/β-catenin signaling pathway and add an additional
translational control axis to this pathway in colon tumorigenesis/familial adenomatous polyposis
and that the elevated eIF3a expression due to β-catenin activation generates free unbound
eIF3a that may gain a non-canonical activity in inhibiting synthesis of tumor suppressor proteins
by binding to their mRNAs. The long-term goal of this project is to understand the mechanisms
of translational control in gene expression, signal transduction, and in aberrant proliferation of
intestinal/colon epithelial cells. Specifically, we will investigate the non-canonical function of
eIF3a in Wnt/β-catenin signal transduction and in colon tumorigenesis and FAP with an ultimate
goal to establish eIF3a as a potential target for drug discovery. To this end, we plan to
accomplish the following specific aims to determine (1) the mechanism of eIF3a action in
translational regulation and in colon tumorigenesis; (2) the mechanism of translational regulation in
tumor suppressor expression, and (3) the mechanism of transcriptional regulation of eIF3a
expression and to establish eIF3a as potential target. The information and probes obtained from
this study will help us understand the molecular mechanisms of translational control axis in Wnt/β-
catenin signaling pathway, the role of eIF3a in translational regulation of tumor suppressor mRNAs,
and to establish eIF3a as a potential target for cancer treatemnts.

Public health relevance
eIF3a is a putative subunit of eukaryotic translation initiation factor eIF3 and it appears to be an important regulator for controlling gene expression at translational level. In this study, we will establish the important role of eIF3a in Wnt/β-catenin signaling and add a novel translational control axis to this pathway, which is important in understanding cell growth control and human colon diseases, and establish eIF3a as a novel drug target.